Identification of a Novel DRG-Specific Long Noncoding RNA and its Role in Neuropathic Pain

Project Abstract
Long noncoding RNAs (lncRNAs) regulate gene expression. Peripheral nerve injury dysregulated their
expression in the pain-related regions including dorsal root ganglion (DRG). However, the role of most
identified lncRNAs in neuropathic pain is still uncertain. Identifying novel lncRNAs and exploring their
contribution to neuropathic pain may provide novel strategies for management of this disorder. We recently
used a next generation RNA sequencing approach and identified a large, native, full-length non-coding RNA in
mice and human. Because it is expressed highly in the DRG, we named it as DRG specific long noncoding
RNA (DS-lncRNA). Our preliminary data revealed that peripheral nerve injury downregulated DS-lncRNA likely
due to a decrease in the expression of a transcriptional activator Pou4f3 in the injured DRG. Rescuing this
downregulation attenuated the nerve injury-induced pain hypersensitivity, likely through blockade of the
increased interaction between RALY (a transcription co-factor) and the RNA polymerase II (RNA II) and
consequent silence of the RALY/RNA II-triggered expression of Ehmt2 mRNA and its coding protein G9a (a
key player in neuropathic pain) in the injured DRG. Given that DS-lncRNA can directly bind to RALY, our
preliminary results indicate that DRG DS-lncRNA downregulation is required for neuropathic pain likely
through negative regulation of DRG RALY/RNA II-triggered G9a expression. This proposal will further
examine whether and how DS-lncRNA contributes to neuropathic pain. In Specific Aim 1, we will first
investigate whether rescuing downregulation of DS-lncRNA in the injured DRG attenuates neuropathic pain
development and maintenance. We will then examine whether mimicking nerve injury-induced downregulation
of DRG DS-lncRNA leads to neuropathic pain symptoms in the absence of nerve injury. In Specific Aim 2, we
will examine whether peripheral nerve injury results in time-dependent downregulation of DS-lncRNA and its
transcription factor Pou4f3 in the DRG. We will also examine whether DS-lncRNA downregulation is attributed
to a decrease of Pou4f3 expression in the injured DRG after peripheral nerve injury. In Specific Aim 3, we will
test the effect of DS-lncRNA on the expression of Ehmt2 mRNA, G9a and their downstream pain-related
genes in the injured DRG after peripheral nerve injury. We will also determine whether DS-lncRNA
downregulation enhances the binding of RALY to RNA II leading to RALY/RNA II-triggered Ehmt2/G9a
increase and G9a-controlled pain-related gene decrease in the injured DRG after peripheral nerve injury. Our
study will likely identify a previously unknown regulatory mechanism for neuropathic pain. Given that virus-
mediated gene therapy has been used in clinical trial, the present study will have a potential clinical
application in neuropathic pain management.

Public health relevance
Project Narrative The proposal will examine a role of recently identified dorsal root ganglion-specific long noncoding RNA (DS-lncRNA) in neuropathic pain. We propose that peripheral nerve injury-induced downregulation of DS- IncRNA may contribute to the development and maintenance of neuropathic pain through enhancement in the binding of RALY (a transcriptional co-factor) to RNA polymerase II and consequent promotion of the RALY/RNA polymerase II-triggered G9a expression in the injured dorsal root ganglion. The proposed study will identify a previously unknown regulatory mechanism for neuropathic pain as well as a novel and potential therapeutic target.